MEDMYST: Dissemination Phase II

[unreadable] DESCRIPTION (provided by applicant): [unreadable] MEDMYST: Dissemination Phase II [unreadable] [unreadable] A Phase I grant, The Reconstructors Investigate Medical Mysteries, from the National Center for Research Resources (R25 RR15295) funded the creation and field-test of innovative web-based materials targeted for middle school students. The product has come to be known as MEDMYST.It is an episodic adventure series with accompanying classroom activities focusing on infectious diseases and the microbes that cause them. The MEDMYST materials consist of: a) web adventures; b) classroom activities; c) MEDMYST Magazine--all designed to engage students in problem-solving activities not likely to be encountered elsewhere. Each of these components is available free of charge on the web site (http://medmyst.rice.edu) and all components are aligned with the National Science Education Content Standards. [unreadable] [unreadable] An extensive field test involving over 700 students from 9 different schools tested the efficacy of these materials. The results, accepted for publication in American Society for Microbiology's Microbiology Education journal, indicated significant learning gains with exposure to the Internet component of the materials. In this Phase II application, the goals are: [unreadable] [unreadable] 1) To create a network of MEDMYST Dissemination Partners and Lead Teachers whose expertise and training will continue beyond the SEPA funding. [unreadable] 2) To amplify teaching of Infectious Disease related concepts though MEDMYST in middle school classrooms by training a minimum of 1200 teachers, who will teach approximately 150,000 students over a two-year period. [unreadable] 3) To evaluate the impact of MEDMYST teacher training and document the adoption process in classrooms. [unreadable] 4) To continue to promote MEDMYST in a variety of educational settings, such as homes, after-school programs, museums, and with links from other web sites. [unreadable] [unreadable] To accomplish these goals, we have formed partnerships with the University of Washington Educational Outreach, The Minnesota Science Museum, the John P. McGovern Museum of Health and Medical Science, and the American Society for Microbiology. [unreadable] [unreadable]